Spinal Manipulation and Patient Self-Management for Preventing Acute to Chronic Back Pain (PACBACK) Study

PROJECT SUMMARY
The US is in the midst of an unprecedented pain management crisis. Guidelines have
recommended non-pharmacologic treatments like spinal manipulation and behavioral
approaches for LBP for nearly a decade, yet uptake and adherence has been poor. Moreover,
little is known about the role of these treatments in the secondary prevention of chronic LBP
(cLBP), especially for patients with biopsychosocial risk factors. With rising costs, mounting
evidence of ineffectiveness, and harms of commonly used drug treatments, including opioids,
there is a critical need for research on non-pharmacological treatments for cLBP prevention that
can be readily translated to practice.
The long-term objective is to reduce overall LBP burden by testing scalable, first-line, non-
pharmacologic strategies that address the biopsychosocial aspects of acute/sub-acute LBP and
prevent transition to cLBP. We are completing a novel randomized hybrid trial addressing both
effectiveness and implementation. A total of 1000 patients have been enrolled with nonspecific
LBP of 2-12 weeks duration, at medium or high risk of developing cLBP. This multi-site,
predominantly pragmatic, phase III trial has two main aims. Aim 1 will assess the effectiveness
of Spinal Manipulation Therapy (SMT), Structured Self-Management (SSM), and SMT+SSM
relative to Medical Care (MC) in a randomized trial using a 2x2 factorial design. Physical
therapists (PT) and chiropractors (DC) will deliver SMT and SSM, and primary care clinicians
will deliver MC. Primary outcomes are prevention of cLBP at 12 months as measured by LBP
Impact and average pain intensity and low back disability over 1 year. Secondary outcomes
include PROMIS-29, productivity loss, healthcare and medication use (including opioids). Aim 2
will use mixed methods to gather data about influences on the interventions that could affect
interpretation of results and future implementation. Qualitative data will lend context regarding
patients’, providers’, and health system leaders’ perceptions; quantitative data will offer insight
on intervention application, adherence, fidelity, and provider confidence.
This project can transform LBP management by providing definitive and generalizable evidence
regarding front-line, non-pharmacologic interventions addressing physical and psychosocial
factors for the prevention of cLBP. Using PTs and DCs to empower patients to engage in healthy
pain management behaviors, we anticipate LBP-related disability, productivity loss, and reliance
on continued healthcare and medication use (including opioids) will be reduced.

Public health relevance
PROJECT NARRATIVE The US is in the midst of an unprecedented pain management crisis, with chronic pain affecting over one third of adults. Low back pain (LBP) is the most common chronic pain condition exacting a huge toll on society in terms of suffering, disability and costs, including those related to opioid misuse, addiction and overdose. Consequently, improving front-line LBP management with non-drug treatments that can prevent LBP from turning chronic has become a critical public health priority.